YAP/TAZ in Schwann Cells as Potential Therapeutic Targets in CMT1A and HNPP.

Project Summary
The heterogeneous group of inherited peripheral neuropathies referred to as Charcot-Marie Tooth disease, have
an estimated prevalence of 1:25001. Among these disorders, Charcot Marie Tooth 1A (CMT1A) and Hereditary
Neuropathy with Liability to Pressure Palsy (HNPP) are the most common1. These diseases result from
duplication (CMT1A) or deletion (HNPP) of the gene encoding for peripheral myelin protein 22 (PMP22)2, leading
to its over or underexpression in Schwann cells (SCs), respectively3,4. There are no cures for these debilitating
diseases, highlighting the need to identify novel mechanisms to modulate PMP22 expression, and to elucidate
the pathological mechanisms involved in peripheral nerve (PN) demyelination. Recently, the complex formed by
the transcriptional coactivator with PDZ-binding motif (TAZ)5 and the transcription factor TEA domain 1
(TEAD1)6,7, was shown to positively regulate PMP22 expression8,9. Therefore, modulation of TAZ activation is
an intriguing therapeutic avenue to decrease PMP22 transcription in CMT1A, or increase its transcription in
HNPP. Moreover, the functions of PMP22 in SC biology include cell cycle regulation10,11, formation of cellular
junctions and myelin permeability12,13, and determining the mechanical properties of myelinated PN fibers14,15.
Notably, these aspects of SC biology are also regulated by TAZ, and the related transcriptional coactivator Yes-
associated protein 1 (YAP)16–20; the major downstream effectors of the HIPPO pathway21,22. Activated YAP/TAZ
translocate to the nucleus and associate with TEAD1-423,24, altering the transcription of many genes essential
for SC proliferation and differentiation including laminin receptors, integrins, G-protein Ga, EGR2, and myelin
and lipid genes8,20,25,26. Therefore, changes in the activation status of YAP/TAZ in CMT1A and HNPP may impact
the physiology of SCs, contributing to demyelination. Thus, we hypothesize that modifying TAZ expression may
restore proper PMP22 expression and ameliorate the phenotypes of CMT1A through direct regulation of PMP22.
We also postulate that YAP/TAZ activation may be altered in mouse models and human samples of CMT1A and
HNPP, potentially contributing to altered SC proliferation, myelin permeability, and mechanical properties of PNs.
To determine the effects of modulating TAZ activation, genetic ablation of TAZ alleles in SCs of PMP22-
overexpressing mice will be assessed for morphological, electrophysiological, sensory, and behavioral
phenotypic rescue. The presence of altered YAP/TAZ activation will be assessed through immunostaining and
biochemical analyses of human biopsy samples and mouse models of CMT1A and HNPP. The research for this
proposed project will be conducted at the Institute for Myelin and Glia Exploration, composed of an
interdisciplinary group of scientists dedicated to the study of myelin and its associated diseases. The overall
training plan will emphasize the development of scientific communication skills, training in various techniques,
improving critical thinking and problem-solving skills, as well as opportunities for regular clinical experiences.
This will create the ideal environment for developing the skills necessary for a career as a physician-scientist.

Public health relevance
Project Narrative: The mechanisms underlying the demyelination observed in the inherited peripheral neuropathies Charcot- Marie-Tooth disease 1A (CMT1A), and Hereditary Neuropathy with Liability to Pressure Palsies (HNPP), are poorly understood. The downstream transcriptional co-activators of the HIPPO pathway, yes-associated protein 1 (YAP), and transcriptional coactivator with PDZ-binding motif (TAZ) are critical for myelination; therefore, it is important to elucidate their role in Schwann cells of CMT1A and HNPP. Furthermore, transcriptional regulation of peripheral myelin protein 22 (PMP22) by TAZ complexed with the transcription factor TEA domain 1 (TEAD1) introduces the possibility for a novel therapeutic avenue in the treatment of CMT1A and HNPP.